Development and Implementation of Optimal Rehabilitation Care Pathways to Reduce Disparities in Rehabilitation Outcomes after Joint Replacement

PROJECT SUMMARY
This NIMHD Mentored Research Scientist Career Development Award (K23) for Dr. Allyn Bove, an Assistant Professor of Physical Therapy at the University of Pittsburgh School of Health and Rehabilitation Sciences, will establish Dr. Bove as an independent investigator with expertise in health disparities in musculoskeletal rehabilitation and use of implementation science methods to trial strategies to mitigate disparities. The proposed research aligns with several of NIMHD’s research interests related to clinical and health services research. This multi-level health services research project aligns with NIMHD’s goals to pursue “multilevel interventions” that seek to “improve access to or quality of care for populations affected by health disparities”. It also aligns with NIMHD’s pursuit of “research to understand factors related to to the adoption of and adherence to evidence-based practices and interventions in healthcare settings”.
The research proposed in this four-year K23 award will occur in three phases. In the first aim, we will engage with provider and patient partners to identify factors related to successful implementation of optimal post-arthroplasty rehabilitation care pathways designed to improve outcomes and mitigate outcomes disparities based on patient race and income/insurance status. In the second stage, we will combine our preliminary data with information from Aim 1 to develop an evidence-based approach for sustainable implementation of optimal rehabilitation care pathways to reduce disparities in community-based rehabilitation and physical function after arthroplasty. In the final step, we will pilot test implementation of these evidence-based novel rehabilitation care pathways. This work is important because it will progress rehabilitation disparities research beyond simply identifying differences toward designing and implementing novel interventions to reduce disparities and improve patient outcomes.
The proposed work draws on Dr. Bove’s prior research on health disparities, qualitative research methodology, and rehabilitation for individuals with osteoarthritis and joint arthroplasty. This work will extend Dr. Bove’s work into the development and implementation of multi-level interventions to address health disparities in this population. Upon conclusion of the proposed research, formal training and mentorship outlined in this K23 application, Dr. Bove will be well-positioned to seek R01 funding for a large hybrid effectiveness/implementation trial of these care pathways that are designed to maximize function and promote improved functional outcomes for all patients after hip and knee arthroplasty surgery.

Public health relevance
Public Health Relevance Section Sociodemographic disparities in physical function and use of rehabilitation following total joint arthroplasty have been established, but there is little to no available research regarding approaches to reduce disparities. In the proposed K23 research, we will develop and test implementation of novel post-arthroplasty rehabilitation care pathways designed to maximize function and reduce race and insurance/income disparities in outcomes. Findings from this project will lead to improved quality of rehabilitation and improved functional outcomes for all patients following hip and knee arthroplasty.